My Mobile Wallet: An Intervention to Support Access to Tuberculosis Care and Medication Adherence in Rural Uganda

Contact PI (Last, First, Middle): Musiimenta, Angella
PROJECT SUMMARY
Significance: Uganda faces a high burden of tuberculosis (TB) with a prevalence rate of 253 per 100,000
people and an incidence rate of 201 per 100,000 people. Poor TB medication constrain treatment success for
the individual and increase its transmission. Financial incentives in form of conditional or unconditional cash
transfers have shown promise for improving TB care but the approach has mainly been implemented in
countries where TB is not a public health priority, and current approaches require costly face-to-face
interactions. Proposed intervention: My Mobile Wallet is a novel behavioral and economic intervention that
utilizes SMS texts to remind medication adherence and utilize mobile money approaches to provide transport
to the clinic and incentivize medication adherence. Our overall hypothesis is that My Mobile Wallet will
overcome behavioral issues, critical financial and motivational issues that currently constrain TB medication
adherence. Innovation: To our knowledge, our study is the first to assess the combination of an objectively
measured adherence, SMS reminders, and behavioral economics-based incentives (delivered via mobile
money) to support TB medication adherence. Approach: In R21 Aim 1, we first determine the optimal design
and develop My Mobile Wallet as an intervention to support TB medication adherence. Using user-centered
approaches, we will iteratively conduct focus group discussions with up to 30 TB patients recruited from the TB
clinic in Mbarara Regional Referral Hospital (MRRH). We then assess the initial feasibility and acceptability of
using My Mobile Wallet to support TB medication, in R21 Aim 2 based on 40 adults with new diagnoses of
active, drug-sensitive TB MRRH. Feasibility will be assessed by receipt of cash transfers, SMS texts received,
and technical problems encountered. Acceptability will be assessed using system usability and interviews
based on the unified theory of acceptance and use of technology. In R33 Aim 1, we further refine and adapt My
Mobile Wallet, and then pilot test it in 10 TB patients over two months of treatment to ensure optimal
functionality. We then assess the refined My Mobile Wallet intervention for large-scale feasibility, acceptability,
and impact on TB treatment adherence and clinical outcomes (in R33 Aim 2) through a randomized control trial
composed of 162 TB patients followed for 6 months. Feasibility and acceptability will be assessed as described
above. Impact assessment will be based on electronically monitored medication adherence (primary), as well
as treatment completion, clinic attendance, cure rates, and mortality (secondary). Investigators/environment:
Our team brings expertise in mobile health technology design and adoption, and behavioral science (Drs
Musiimenta and Haberer), and behavioral economics (Dr. Linnemayr). Future directions: My Mobile Wallet is
designed with limited infrastructure needs, thus creating potential for real world implementation at scale that
can be tested in a future multisite cluster randomized (R01 grant).

Public health relevance
Contact PI (Last, First, Middle): Musiimenta, Angella PROJECT NARRATIVE TB is a serious public health concern which kills more people annually than HIV and malaria combined, and poor treatment adherence limits the success of TB treatment and increases TB transmission. SMS texts and real-time adherence monitoring may provide low-cost and acceptable alternative approaches to supporting TB medication especially in settings where DOT is difficult to implement, while incentives may overcome financial and motivational issues that currently constrain medication adherence. My Mobile Wallet is a novel intervention that utilizes SMS texts to remind medication adherence, and utilize mobile money-based approaches to provide transport to the clinic, and motivate medication adherence.